Oral Therapeutics Platform for Treating Inborn Errors of Amino Acid Metabolism

Project Abstract
Syntis Bio is pioneering a groundbreaking approach to treat Homocystinuria (HCU), a metabolic
disorder caused by a defect in the cystathionine-β-synthase enzyme, by developing a once-daily
oral therapy utilizing a gastrointestinal synthetic epithelial lining (GSEL™) combined with a
protease-stable methionine-gamma-lyase (MGL). This innovative strategy aims to effectively
manage elevated levels of homocysteine and methionine by enhancing the retention and activity
of MGL in the small intestine, thereby addressing both ingested and recirculated methionine
without the downsides of current invasive treatments. In this SBIR Fastrack proposal, we propose
to optimize an MGL-GSEL formulation (SYNT-202) for robust gastrointestinal adhesion and
stability, demonstrate its efficacy in reducing homocysteine levels in mouse models and validate
its tolerability and biocompatibility in larger animal models. The goal is to produce a solid dosage
form that simplifies administration, ensuring a feasible, long-term disease management strategy
for HCU patients and potentially other metabolic disorders, leading to improved dietary flexibility
and quality of life.

Public health relevance
Project Narrative Syntis Bio is developing SYNT-202, a once-daily oral therapy for Homocystinuria using a gastrointestinal synthetic epithelial lining and protease-stable methionine-gamma-lyase to manage homocysteine and methionine levels.